Improving Engagement with Vaginal Dilator Therapy after Pelvic Radiation: A Pilot Randomized Controlled Trial

Survivors of gynecologic, anorectal, and urologic cancers often complete pelvic radiation therapy, resulting in
many survivors (38-80%) developing shortening or narrowing of the vagina (i.e., vaginal stenosis). Vaginal
stenosis may cause patients to avoid or be unable to complete pelvic exams for cancer surveillance due to pain
or vaginal obstruction. Vaginal stenosis may also cause painful sexual intercourse. Dilator therapy is the primary
treatment for preventing and treating vaginal stenosis. However, engagement with dilator therapy is poor. There
are modifiable biopsychosocial barriers to dilator therapy engagement (symptom burden [e.g., pain, vaginal
dryness], emotional distress, dilator knowledge), but few interventions have addressed modifiable barriers and
improved engagement with dilator therapy. If engagement remains poor, survivors are at risk for missing critical
cancer surveillance, emotional distress, impaired sexual and relational functioning, and poor quality of life.
Grounded in the NIH stage model, this study aims to develop, refine, and pilot test a novel behavioral
intervention, informed by the Health Belief Model, to enhance engagement with dilator therapy among female
cancer survivors who underwent pelvic radiation. In Phase I, individual qualitative interviews with patients in the
target sample (N=20) and medical providers (N=10) will be used to inform intervention development. It is
anticipated that the intervention will employ strategies from cognitive behavioral therapy and acceptance and
commitment therapy. In Phase II, the intervention will be refined through user testing interviews (N=12). In Phase
III, feasibility and acceptability of the intervention will be examined, as well as patterns of change in primary
(frequency and duration of dilator use) and secondary (symptom burden, emotional distress, and dilator therapy
knowledge) outcomes of interest, through a pilot randomized controlled trial. Participants (N=88) will be
randomized to the intervention or enhanced usual care and complete 4 primary assessments (baseline and 3,
6, and 9 months post-baseline) plus a brief monthly survey evaluating dilator use. In line with the NCI’s priority
area of cancer survivorship, the overall goal of the award is Dr. Stalls’ becoming an independent clinical scientist
with expertise in developing, evaluating, and disseminating behavioral interventions to improve sexual health
among cancer survivors. To do so requires a unique combination of knowledge and skills: 1) Sexual Health
among Cancer Survivors, 2) Sexual Health Research and Advanced Qualitative and Quantitative Research
Methods, 3) Randomized Controlled Trials Design and Conduct, and 4) Leadership and Professional
Development. Dr. Stalls will accomplish these career development goals through training with expert mentors,
collaborators, and consultants as well as capitalizing on the resources and training opportunities at Duke
University and Duke Cancer Institute. Completion of this award would strengthen the cancer research workforce,
a direct mission and priority area of the NCI; Dr. Stalls’ developed expertise would help address a national gap
in clinician scientists working at the intersection of behavioral oncology and sexual health.

Public health relevance
Although much of the growing population of adult cancer survivors in the United States will face sexual health concerns secondary to their cancer and cancer treatments, survivors consistently report that sexual health concerns go unaddressed, and there are critically few clinician scientists with the expertise to address these sensitive concerns, representing a significant public health challenge. This project will develop, refine, and examine the feasibility and acceptability of a behavioral intervention that aims to improve engagement in vaginal dilator therapy among cancer survivors who received pelvic radiation and are at risk for vaginal stenosis. The intervention developed through this study has the potential to produce significant public health benefits; in addition to improving engagement in dilator therapy, the intervention could be modified and applied to improve the use of other equally important and sensitive sexual health rehabilitation interventions among a wide array of chronic health populations.